Small Molecules and Biologics Toxicology Consultant Support Services

The Subject Matter Expert Consultant for Toxicology provides technical guidance to the following programs:
• Toxicology consulting support to the NIH Blueprint Neurotherapeutics Network [BPN] drug discovery and development programs.
• Toxicology consulting support to the Help End Addiction Longterm [HEAL] drug discovery and development programs.
• Other NIH neuroscience-focused drug discovery and development programs.

The NIH Blueprint for Neuroscience Research, a consortium of 8 NIH Institutes and Centers that support neuroscience research, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and contract research organization (CRO) support through Phase I clinical testing.

The NIH HEAL Initiative is an aggressive, trans-agency effort to speed scientific solutions to stem the national opioid public health crisis. The Initiative advances research to reduce the risks of opioid use and misuse and improve pain management, thereby reducing reliance on opioids.

The HEAL program supports preclinical optimization and development of safe, effective, and non-addictive small molecule and biologic therapeutics to treat pain. The goal of the program is to accelerate promising small molecule and biologic hits/leads towards clinical trials. The HEAL program will provide neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise.